Molecular mechanisms underlying lineage plasticity in prostate cancer

PROJECT SUMMARY/ABSTRACT
Prostate cancer arises as an androgen driven disease, and systemic therapies that target the androgen receptor
(AR) are used to treat patients at all stages of the disease. In recent years, with the earlier and more potent
targeting of the AR with newer drugs, AR-independent prostate cancer has emerged. We have found that this
is associated with lineage plasticity in which upon selective therapeutic pressure, tumors evade AR-therapy
through loss of luminal prostate identity (including AR) and the acquisition of alternative lineage programs
including neuronal/neuroendocrine, stem-like, and developmental pathways. In extreme cases, tumors may
completely transition from an AR-positive prostate adenocarcinoma (PADC) toward an AR-negative small
cell/neuroendocrine carcinoma (NEPC). This phenotypic change is associated with clinical and molecular
features similar to small cell lung cancer, manifest by rapid progression and lethal disease. We have integrated
patient and preclinical data to identify and molecularly characterize genes and pathways that drive lineage
plasticity including the combined loss of TP53/RB1, suppression of the Notch signaling pathway, and up-
regulation of lineage-determining transcription factors (LDTFs) including ASCL1 and INSM1. We hypothesize
that loss of Notch signaling activates LDTFs, which act coordinately with super-enhancers and chromatin
regulators to drive lineage plasticity, loss of AR signaling dependence, and NEPC progression. To test this
hypothesis, we will investigate the role of NOTCH-INSM1 signaling in regulating LDTFs to drive NEPC
progression and treatment resistance (Aim 1); extensively characterize the super-enhancer landscape and
transcriptional reprogramming that governs lineage plasticity (Aim 2); and elucidate the transcriptional network
of LDTFs that promote tumor evolution from an AR-driven state towards non-AR driven disease (Aim 3). This
proposal will not only enhance our understanding of tumor evolution and cell identity, but will also identify new
therapeutic approaches to target lineage plasticity. These are critical steps towards improving the early
detection, treatment, and mortality of prostate cancer patients developing treatment resistance. Results may
also have relevance in other cancer types that develop lineage plasticity to evade effective targeted therapies,
such as lung cancer, melanoma, and breast cancer.

Public health relevance
PROJECT NARRATIVE A subset of prostate cancers evolve in the face of therapy to look less like a typical prostate cancer and more like a small cell neuroendocrine carcinoma, as a means to bypass treatment. Here, we will integrate patient data and preclinical models to assess the molecular mechanisms driving drug resistance and determine how lineage specific transcription factors regulate cellular reprogramming and the tumor’s epigenetic state to facilitate this change in identify. We will identify the context and cooperation of key drivers of disease progression and drug resistance that will lead to new strategies to improve the early detection, treatment, and mortality of patients with treatment resistant prostate cancer.